Gabriella Miller Kids First Pediatric Data Resource Center: Advancing Collaborative Platform-Enabled Data-Driven Discovery at the Intersection of Childhood Development and Cancer

PROJECT SUMMARY
Since its launch, the Gabriella Miller Kids First Data Resource Center (KFDRC) has constantly innovated and
helped redefine the architecture, development and operations across all cores of work to optimize and provide
opportunities for the research community to have impact in childhood cancer and structural birth defects. This
has included collaborative partnerships across the NIH data commons landscape to ensure the FAIRness of
Kids First data and enable rapid access of data in cloud-based platforms. In the next phase, the KFDRC will
build on these innovations and successes to further empower sustained, scaled growth and impact. This will be
a cross-coordinated effort across the Administrative and Outreach Core, the Data Coordinating Core and the
Data Resource Core. The combined efforts of these cores will provide researchers the data, tools, and
workspaces they need to further the mission of the Kids First program. The KFDRC will make significant
contributions to accelerate community efforts not only to understand etiology and drivers of pediatric diseases,
but also drive and enhance the interpretation and clinical decision support for better outcomes for children.

Public health relevance
PROJECT NARRATIVE The Kids First Data Resource Core (KFDRC) is composed of three core, the Administrative and Outreach Core (AOC), the Data Coordination Core (DCC) and the Data Resource Core (DRC), which together will facilitate making Kids First, and other relevant interoperable datasets, Findable, Accessible, Interoperable and Reusable (FAIR). In this phase, the KFDRC will expand and scale its efforts for continued data generation, new data modalities, emerging interoperability initiatives and wider range of users across computational and biological researchers, to clinicians to patients and patient advocates. These efforts will continue to maximize the potential for novel discovery and better understanding across a multitude of pediatric diseases and disorders for clinical translation.